Linking Alcohol Use Disorder and Social Anxiety Disorder: The Role of Positive Emotions

PROJECT SUMMARY
The proposed research study applies positive emotion regulation models to identify within-person and
between-person transdiagnostic mechanisms that contribute to comorbid Alcohol Use Disorder (AUD) and
Social Anxiety Disorder (SAD). SAD is an important risk factor for the development of AUD, and comorbid SAD
and AUD confer greater detrimental effects on public health-related outcomes than either disorder alone.
Building on critical foundational work using negative emotion regulation models to explain comorbid AUD and
SAD, the current proposal focuses on positive emotion regulation, particularly difficulty accepting positive
emotions, which may also play a critical role in driving comorbidity. Past research has established that people
high in SAD symptoms have difficulties regulating positive emotions, including difficulty accepting positive
emotions. Although people with AUD often experience deficits in positive emotion regulation in their daily lives
(i.e., when sober), there is evidence suggesting that, in the short term, alcohol use facilitates adaptive positive
emotion regulation. For example, a recent ecological momentary assessment (EMA) study found that alcohol
weakened the relation between state SAD symptoms and reported social interaction quality. Specifically, when
participants did not consume alcohol, state SAD symptoms predicted worse social interaction quality, but when
they did consume alcohol, state SAD symptoms did not affect social interaction quality. Thus, an understudied
area of research is whether alcohol consumption temporarily allows individuals with elevated SAD symptoms
to accept positive emotions, which, in the long term, could lead to alcohol-related problems. Aim 1: Using EMA
methodology, test whether, on a within-person level, alcohol consumption moderates the day-to-day temporal
relation between state SAD symptoms and difficulty accepting positive emotions in young adults at risk for both
AUD and SAD. It is expected that greater state social anxiety symptoms will predict greater difficulty accepting
positive emotions, but alcohol will moderate (weaken) this relation. Aim 2: Test whether, on a between-person
level, the extent to which alcohol helps people accept positive emotions is associated with alcohol-related
problems across participants. It is expected that the effectiveness of alcohol in reducing the deleterious impact
of SAD on difficulty accepting positive emotions will be correlated with greater alcohol-related problems. By
clarifying whether alcohol consumption’s benefit to positive emotion regulation (e.g., increasing acceptance of
positive emotions) contributes to problematic alcohol use, results of this study may provide preliminary
evidence of important public health-related targets for prevention and intervention in those at risk for AUD. This
research proposal and corresponding training plan allow the applicant to obtain extensive training in EMA
methods and data analysis tools and provide opportunities for professional development (e.g., conference
presentations, manuscript publications, grantsmanship), both of which are fundamental to the applicant’s
career goal of becoming an independent clinical scientist studying comorbid anxiety and AUD.

Public health relevance
PROJECT NARRATIVE Social Anxiety Disorder (SAD) is an important risk factor for development of Alcohol Use Disorder (AUD) and comorbid SAD and AUD confer greater detrimental effects on public health-related outcomes than either disorder alone. This link between the disorders may be explained in part by difficulties accepting positive emotions. The proposed study uses ecological momentary assessment methodology to investigate whether alcohol consumption weakens the day-to-day temporal relation between state SAD symptoms and difficulty accepting positive emotions, and whether the extent to which alcohol helps people accept positive emotions is associated with alcohol-related problems across individuals.